Mechanisms of Hedgehog signaling in glioblastoma

Project summary
Glioblastomas are deadly tumors and account for approximately half of all malignant primary brain cancers.
Glioblastoma stem cells exist in interchangeable cellular states that are influenced by the tumor
microenvironment, and there is a paucity of information concerning the cellular mechanisms responsible for
communicating between glioblastoma cells and the tumor stroma. The Hedgehog pathway, which directs gene
expression programs that are essential for development and adult stem cell homeostasis, is critical for survival
of glioblastoma stem cells. Paradoxically, a clinical trial suggested that pharmacologic inhibition of the Hedgehog
pathway accelerates glioblastoma growth. These clinical data provide an opportunity to re-evaluate how the
Hedgehog pathway functions in cancer, and suggest that the role of Hedgehog signaling in glioblastoma stem
cells remains to be elucidated. This proposal focuses on understanding how inhibition of the Hedgehog pathway
drives glioblastoma at the tumor, cellular, and molecular scale. To do so, our proposal incorporates a novel
astrocyte organoid model of glioblastoma that facilitates live imaging of cellular interactions within the tumor
microenvironment. When integrated with CRISPR interference, pharmacology, and mouse syngeneic and
patient derived xenograft models of glioblastoma, our innovative organoid system will facilitate previously
impossible experiments to understand glioblastoma biology. Based on our preliminary organoid, in vivo, and
single cell RNA sequencing data presented in this application, we hypothesize that cancer cell-extrinsic
Hedgehog signaling in the tumor microenvironment restrains glioblastoma stem cell-renewal and invasion by
inducing differentiation factors and remodeling the extracellular matrix. We will test this hypothesis by defining
how Hedgehog signals are transduced through the glioblastoma microenvironment; determining if cancer-cell
extrinsic Hedgehog signaling restrains glioblastoma stem cells by inducing bone morphogenic protein signaling;
and determining if Hedgehog signaling restrains glioblastoma cell invasion by inducing genes that regulate
migration through the extracellular matrix. This approached is based on the premise that by studying the
mechanisms of Hedgehog signaling in glioblastoma, we will discover new insights into how glioblastoma cells
communicate with the tumor microenvironment. Indeed, we know surprisingly little about how interactions
between glioblastoma cells and the tumor microenvironment influence cancer progression, and almost nothing
about how astrocytes, which comprise the majority of cell types in the adult brain, influence glioblastoma invasion
or tumorigenesis. Though the objective of this proposal is to broadly improve our understanding of the
mechanisms of Hedgehog signaling in glioblastoma, a long-term goal of this research is to understand these
processes well enough to consider targeted therapeutic strategies to improve survival from glioblastoma. Thus,
this work will explain why Hedgehog pathway inhibition unexpectedly accelerates glioblastoma growth, elucidate
targetable mechanisms, and provide the preclinical basis for new clinical trials in glioblastoma patients.

Public health relevance
Project narrative This proposal focuses on mechanisms of Hedgehog signaling through the tumor microenvironment in glioblastoma, an incurable cancer of the central nervous system and the most common primary malignant brain tumor. Our objective is to understand why pharmacologic inhibition of Hedgehog signaling unexpectedly accelerates invasion and tumorigenesis of glioblastoma cells. Using a novel human astrocyte organoid model of glioblastoma and patient derived xenografts, this work will provide fundamental insights into how the Hedgehog pathway functions in cancer, and establish the preclinical basis for new clinical trials in glioblastoma patients.